Investigation of neuraminidase as a target antigen for a universal influenza virus vaccine

PROJECT SUMMARY
Influenza A (IAV) viruses cause significant global morbidity and mortality annually, and unpredictable pandemic
viruses emerging at irregular intervals pose a significant threat to public health. Current seasonal influenza virus
vaccines elicit strain-specific immunity with variable effectiveness, depending on the degree of matching with
circulating virus strains. Importantly, these vaccines do not confer protection against novel pandemic or emergent
viruses. As such, a more effective “universal” influenza virus vaccine that provides broader protection against
the increasing diversity of strains and subtypes is urgently needed. Such efforts should prioritize the identification
and targeting of novel broadly protective epitopes capable of eliciting heterosubtypic and/or pan-group immunity.
Moreover, this work should prioritize the investigation of exotic IAV subtypes from emerging zoonotic viruses, as
highly pathogenic avian influenza (HPAI) infections are increasingly prevalent, and these viruses are considered
a serious global health threat. In addition to IAV hemagglutinin (HA), the viral neuraminidase (NA) represents a
worthy, but currently understudied universal influenza virus vaccine target.
In this F31 application, I will address these gaps in our knowledge, generating tools to identify broadly protective
epitopes on influenza neuraminidases (NA) from exotic, under-investigated subtypes from emerging zoonotic
viruses and deepen our understanding of NA-based mechanisms of protection. In Aim 1, we will validate a panel
of NAs as structurally, functionally, and antigenically authentic. Lead candidates will be used for the development
of unique nanobodies which we will use as tools to aid the identification of novel broadly cross-reactive epitopes.
In Aim 2, lead NA candidates will be incorporated into non-replicating adenovirus (Ad) vectors, and we will
assess the in vivo immunogenicity of Ad5-NA vaccines to identify innovative heterologous prime:boost regimens
best suited for eliciting breadth. Monoclonal antibodies (mAbs) will be isolated from vaccinated mice and
evaluated, in parallel with isolated nanobodies, in vitro for breadth and functionality, and in vivo for efficacy in
IAV challenge studies. Finally, we will use structure-based approaches to identify the binding footprints of
promising lead mAbs/nanobodies. Efficacy data will be linked with data from structural (i.e. epitope mapping)
and in vitro analyses to identify broadly protective, cross-reactive epitopes. By completing the aims of the
proposed research, we will improve our understanding of protective epitopes on under-studied NA subtypes from
emerging zoonotic viruses and generate unique tools and reagents for pandemic preparedness. Together,
these efforts to improve our understanding of NA-based immunity at an epitope level will contribute to
the next-generation design of more broadly protective universal influenza vaccines for pandemic
preparedness.

Public health relevance
PROJECT NARRATIVE Vaccination is the most effective way to mitigate the significant public health threat that emerging influenza A viruses (IAV) pose; however, current seasonal vaccines elicit strain-specific immunity that does not protect against novel pandemic or emergent viruses, and much of the current influenza vaccine development is focused on the major surface glycoprotein, hemagglutinin. In this application, we will investigate IAV neuraminidase as an alternative target antigen for a broadly protective, “universal” influenza vaccine. The findings of this work will improve our current understanding of neuraminidase-based immunity and how it can advance the design of next- generation universal influenza vaccines for pandemic preparedness.